Developmental Biology Training Program

PROJECT SUMMARY
The University of Oregon's long-standing predoctoral Developmental Biology Training Program's goal is to
train rigorous, skilled, and innovative developmental biologists. Our trainees develop abilities to lead research
programs of their own, communicate discoveries to other scientists and the public, and teach future
generations of scientists. Our multi-faceted training equips students to become leading academic and non-
academic scientists or achieve other influential research-related careers.
Individualized research training within one of many active and diverse laboratories is the core of our program.
Trainees' thesis research builds upon a continuously innovating curricular foundation. Core graduate-level
courses are Molecular Genetics and Developmental Genetics and one of Developmental Neurobiology, Stem
Cells & Regeneration, and Genomics Approaches. Additionally, all trainees take Advanced Biological
Statistics. We surround research and coursework with a wealth of enhancing and broadening experiences.
Examples include first year rotations, required teaching, a dissertation advisory committee, journal clubs, a
monthly interest group, annual student research reports, and interactions with visiting speakers. We offer
various career development activities especially to support students interested in non-academic careers. A
unique highlight is our annual trainee-organized Developmental Biology Training Program symposium, where
trainees host leading scientists to share their research on a topic of the students' choosing.
We request continued support for seven predoctoral positions within a program that includes 22 highly
collaborative, productive, and well-funded labs dedicated to graduate training. We have expanded the reach
and vitality of our research and training with six new Assistant Professors, all of whom are top recruits and
represent diverse areas of developmental biology research. They join the DBTP's internationally respected
senior faculty to position us to maintain our outsized record of innovative research and training. The DBTP
unites faculty and trainees from two Departments (Biology or Chemistry & Biochemistry) and four Institutes
(Institute of Molecular Biology, Institute of Neuroscience, Institute of Ecology and Evolution, Oregon Institute of
Marine Biology). Trainees are exposed to research across Institutes due to a rich tradition of collaboration,
common training activities, the close proximity of most labs, and outstanding core facilities. As such, our
program fosters interdisciplinary training that bridges genetics, genomics, molecular biology, cell biology,
computational biology, neuroscience, and evolutionary biology. This breadth complements the focused project-
oriented training students receive in their thesis labs, producing creative and confident scientists empowered to
direct impactful research programs or assume other science leadership roles.

Public health relevance
PROJECT NARRATIVE Our long-standing predoctoral Developmental Biology Training Program prepares creative and rigorous scientific leaders. Development biology research reveals mechanisms that go awry in congenital defects and adult diseases, including many cancers that arise from uncontrolled developmental programs. A detailed understanding of these diseases, and thus the rationale design of innovative diagnostics and therapeutics, depends on multifaceted training of the next generation of developmental biologists.